New York Regional Center for Diabetes Translation Research

Administrative Core
The Administrative (ADM) Core of the New York Regional Center for Diabetes Translation Research (NY-
CDTR) provides the fundamental infrastructure necessary to strengthen such research at the Albert Einstein
College of Medicine with Montefiore Health Systems, and other diverse partnering institutions of our Core
faculty and members to stimulate the next generation of diabetes translation research through the following
aims: 1) To provide dynamic and responsive leadership. The ADM will afford consistent scientific leadership to
articulate and implement a clear vision for the translational research direction of the Center. The Program
Director, Jeffrey Gonzalez, PhD, will provide strong and responsive leadership to accelerate translational
research on diabetes and obesity that contributes to health equity in diabetes outcomes for ethnic/racial
minorities, the poor and disadvantaged, and other marginalized groups. 2) To provide robust infrastructure for
the maintenance of four cutting edge Translational Research Cores. We have developed and refined four
Translational Research Cores furnishing the infrastructural bedrock of the NY-CDTR: Behavioral Science and
Technology Core; Life Course Methodology Core; Population Health and Health Systems Core; and the Latino
Network for Diabetes Translation Research, a National Resource Core. 3) To administer vibrant Center
Programs, including an Enrichment Program and a Pilot and Feasibility (P&F) Grant Program. The ADM will
leverage the many resources of our collaborating academic institutions, funded Centers and CTSAs, so that
the Enrichment Program activities are accessible for members as well as potential new members; there is also
a heightened awareness of the wealth of educational programs for diabetes translational investigators focused
on health equity research. The ADM will also provide infrastructure and support for the robust, mentored P&F
Program to fund promising research proposals from early stage investigator members. Maintenance of a useful
and up-to-date NY-CDTR website will make these resources accessible to our members and non-members
across the country. We will also stimulate and promote use of diversity supplements throughout our national
network. 4) To objectively evaluate progress, facilitate efficiency, and ensure ethical conduct of research, and
quality control, with guidance from multi-stakeholder and community-based advisors. The ADM institutes a
system of reportage and evaluation to ensure that services meet expectations; initiatives continue to be
effective; progress is reported in a timely and comprehensive manner; and established objectives continue to
be met. The ADM will work with an Internal Advisory Committee and External Scientific Advisory Committee to
ensure the cost-efficient and high impact performance of all Center activities to guide the evolution of the NY-
CDTR toward the next generation of diabetes translation research that is responsive to community needs and
priorities, funding opportunities, and developments in technology.